A nanofiber-hydrogel composite plug for perianal fistula repair

SUMMARY
Perianal fistulas (PAF) occur in 30-40% of Crohn’s disease patients and their complications lead to a
significant impairment in quality of life. Current treatments are effective in less than 50% of cases. The overall
objective of this proposed study is to develop a biostimulatory nanofiber-hydrogel composite (NHC) plug to
promote tissue healing and to test its efficacy to repair PAF in clinically relevant animal models. Previous work
from the Mao and Selaru labs laid the foundation for this study. Specifically, we have established novel rodent
and swine models of PAF that faithfully recapitulate the biology of PAF in patients. In parallel, we have developed
a first-generation injectable biodegradable nanofiber-hydrogel composite (NHC) from poly(e-caprolactone) (PCL)
nanofibers covalently bonded to hyaluronic acid (HA) hydrogel; and demonstrated its ability to deliver adipose
stem cells (ADSCs) and repair PAF by conditioning inflammatory responses, permitting host cell infiltration, and
facilitating angiogenesis and progressive remodeling. Building on these preliminary results, we plan to engineer
a second generation NHC plug with enhanced mechanical strength and integrity as an off-the-shelf device and
optimize its biostimulatory activities to induce more favorable cellular responses governing fistula healing. We
hypothesize that this NHC plug with structurally, mechanically, and biofunctionally optimized features will
effectively promote angiogenesis and soft tissue restoration; and serve as a carrier for ADSCs and ADSC-
derived exosomes to further improve the PAF tissue healing. To test this hypothesis and demonstrate its
translational potential, we will pursue three specific aims (1) develop a collagen nanofiber-based NHC plug with
optimal mechanical properties and porous structure for ease of implantation to support perianal fistula healing,
(2) utilize a rat model to evaluate the efficacy for PAF healing when used alone or in conjunction with ADSCs or
ADSC-derived exosomes, and elucidate the pro-regenerative mechanism by assessing cell infiltration,
angiogenesis, extracellular matrix deposition, and tissue remodeling, and (3) utilize a swine model to
demonstrate the synergistic effect in tissue remodeling by combining the optimized NHC plug with ADSC-derived
exosomes. This study will deliver a translatable off-the-shelf biomimetic NHC microporous plugs for the delivery
of ADSC-derived exosomes capable of promoting soft tissue remodeling and healing for PAF repair.

Public health relevance
PROJECT NARRATIVE There are no effective treatments for perianal fistula (PAF), which occurs in up to 40% of Crohn’s disease pa- tients. This proposed study aims to develop a biostimulatory nanofiber-hydrogel composite plug to promote tissue healing and test its efficacy to repair PAF in rodent and swine models in conjunction with adipose-de- rived stem cells (ADSCs) or ADSC-derived exosomes. If successful, this study will offer a translatable off-the- shelf biomimetic NHC microporous plugs for PAF repair and tissue healing.